Cancer Research Training & Education Coordination

PROJECT SUMMARY/ABSTRACT
CANCER RESEARCH TRAINING AND EDUCATION COORDINATION
The goals of the Cancer Research Training and Education Coordination Core (CRTEC) of Winship Cancer
Institute of Emory University (Winship) are: (1) to provide research training and education opportunities to build
a pipeline of diverse cancer researchers; (2) to ensure their success through mentorship and career development
programs; and (3) to leverage existing programs across Emory University to enhance cancer research training
and education. To facilitate these goals, Winship has made a significant annual investment averaging
$850,000/year during the present funding period in education and training programs. Winship has a long-
standing record of developing and supporting cancer-focused programs for the spectrum of learners from middle
school through graduate school. In addition, through collaborative partnerships, cancer-related training has been
integrated into training programs across Emory University. CRTEC has facilitated successful submission of F-
and K- applications from trainees across all four Winship research programs. For post-graduates, Winship career
development activities include support for early career investigators through programs for physician-scientists,
NCI K12 award in Clinical Oncology for physicians, and an American Cancer Society Institutional Research
Grant (ACS-IRG) with Diversity in Cancer Research supplements that include summer support for undergraduate
students and pilot funding for early-stage investigators from historically underrepresented groups. A pre-
submission review process by the Winship Scientific Research Council and Shared Resource Leaders is in place
for trainees and faculty to enhance successful outcomes for grant submissions. Winship also provides numerous
continuing education opportunities for faculty, staff, and clinicians in the community. As a result of these efforts,
36 trainees across three T32 programs conducted cancer research during the reporting period. Since 2016, 24
students in Winship member labs received an F31, four received an F30 and 5 received F99 awards. Of 31
domestic students in the Cancer Biology Graduate Program, 12 (39%) were from populations underrepresented
in STEM. Sixteen out of 17 graduates of the Winship-supported Research Ethics Fellowship Program proceeded
to a career in medicine or research. Taken together, CRTEC promotes high quality cancer training to develop
the next generation of cancer clinicians and researchers to transform cancer research, prevention, care, and
education and reduce the cancer burden in the Winship catchment area.